RPA-Directed DNA Repair Mechanisms

Project Summary
Replication protein A (RPA) is required for nearly every DNA repair and replication process. RPA binds single-
stranded DNA and interacts with dozens of proteins at sites of DNA maintenance. We are interested in the
protein complexes that form between RPA and other proteins when performing specific DNA repair tasks. The
current project examines RPA’s role as a central scaffold in uracil base excision repair. Our approach is to
manipulate the binding of RPA to Uracil DNA Glycosylase (UNG2) to examine the relevance of their
interaction. We have developed a strategy to covalently tether together RPA and UNG2 to form mini DNA
repair complexes that resemble the architecture of the two proteins when they interact in cells. Our Preliminary
Data demonstrates our success at forming RPA-UNG2 protein complexes in both cellular and recombinant
systems. This allows us to definitively determine how RPA functions as part of a protein complex with UNG2,
and complementary studies examine the effects of weakening their association. Specifically, Aim 1 uses
purified RPA and UNG2 constructs to examine the activity of the proteins alone or as part of a complex.
Binding and enzymatic experiments using synthetic DNA substrates will determine the structural nature of their
substrates in vivo. We focus specifically on the action of RPA and UNG2 at ssDNA-dsDNA junctions, their
known substrates, by preparing uracilated fork-like DNA structures that resemble replication forks found in the
nucleus. Aim 2 examines the RPA-UNG2 protein complex in human colorectal cells under conditions of uracil
stress that are induced by commonly used chemotherapeutic agents. The strength of RPA’s interaction with
UNG2 will be controlled and correlated with UNG2’s uracil excision efficiency at the replication fork. Finally,
additional cellular proteins that associate with RPA and UNG2 will be identified. The function of these proteins
will be examined in the context of multi-protein complexes that form during uracil base excision repair. The
targeted scope of this project examining RPA in base excision repair will facilitate our methodological
development, which will be widely adaptable for examining RPA-containing protein complexes in other DNA
repair processes.

Public health relevance
Project Narrative DNA is constantly damaged in cells and must be repaired to maintain cellular health. This application examines protein complexes that form during a DNA repair process called uracil base excision repair. Uracil base excision repair regulates several biological processes including adaptive immunity, the infectivity of certain viruses, and the efficacy of specific chemotherapeutics.